Novel carbohydrate binding functions of the CR3 I-domain modulate gonococcal-cervical cell interactions

PROJECT SUMMARY
The prevalence of Neisseria gonorrhoeae (Ng), its associated morbidity, and the emergence of untreatable
strains, support a critical need for new preventative and therapeutic strategies for this important human-
pathogen. Such developments require a complete understanding of the pathobiology of this archetypal, host-
adapted pathogen. We show that phase-variable, glycan post-translational modifications on Ng surface
appendages, pili (fimbriae), play a vital role in human infection. Complement receptor 3 (CR3) is an important
pattern recognition receptor that is the key receptor mediating Ng colonization of human cervical mucosa. CR3
contains an “I-domain” region, which is known as a binding site for protein ligands. However, we found that
Ng binding to the I-domain is mediated by the pilin-linked glycan (PLG). This is a seminal finding in innate
immunity, as all previous literature ascribe CR3 carbohydrate binding to a separate, so called "lectin" domain.
This was also the first demonstration that post-translational modifications made to a bacterial protein
modulate pathogenesis. These findings will impact our understanding of microbial pathogenesis and innate
immune responses. The goals of the present application are to define the specific contribution of the six,
naturally occurring, PLG structures in mediating the Ng-CR3 I-domain interaction and to determine the
biological relevance of each of these interactions to infection in females. Guided by strong preliminary data, we
hypothesize that variable PLG structures initiate key, but highly divergent, outcomes with CR3 I-domain
engagement. We will resolve our hypothesis through two specific aims: Aim 1) Define the effect of variation in
pilin glycan structure on direct PLG-I-domain interactions; we will define the specific molecular interactions
occurring with the CR3 I-domain for the six natural Ng PLG structures. Aim 2) Define the effect of PLG-I-
domain interactions on Ng pathogenesis and CR3 function; we will define targeted epithelial cell responses to
CR3 I-domain engagement by Ng that bear different PLG structures and their effect on Ng pathogenesis. Our
approach is innovative in using biologically relevant human primary cervical cells, both alone and in co-culture
with phagocytes, combined with low passage Ng isolates. This ensures that data obtained are relevant to
human processes. By defining the effector functions controlled by I-domain lectin activity on primary human
epithelial cells, we will provide critical new information regarding Ng pathogenesis, CR3 function, and the
fundamental mechanisms that govern human cervical mucosal immunity. Moreover, we will define the utility
of targeting the PLG-CR3 I-domain interaction as a new, and improved, host-targeted approach to treat and/or
prevent Ng disease in women. Our studies will very likely impact work on other human pathogens and on
innate immunity, broadening the significance of our outcomes. We have extensive experience in defining the
molecular mechanisms of Ng pathogenesis. We are ideally placed to do this work in having discovered CR3 as
the key receptor for Ng cervical infection and the biosynthetic pathways for pili glycosylation.

Public health relevance
PROJECT NARRATIVE We discovered that an important receptor of the immune system, CR3/Mac-1, is present within the female reproductive tract. Using the bacterium that causes gonorrhea, the intent of this application is to define how different sugars added to bacterial proteins may affect the unique innate immune function of CR3 on the surface of the female reproductive tract. This information will provide new insights into the immunity of the female reproductive tract as well as into gonococcal disease, which will aid the future development of new approaches to diagnose, treat, and prevent gonorrhea.